Assessment of restoration of an internally deleted dystrophin as a surrogate biomarker for future clinical trials of a gene editing therapy in Duchenne muscular dystrophy

Project Summary
Duchenne muscular dystrophy is a rare genetic muscle disease affecting ~16,000 patients in the
US. It leads to premature death in the twenties to thirties and has no cure. Gene editing offers an
innovative solution for Duchenne since it can be used to permanently remove patient mutations
in the endogenous gene and restore an internally-deleted and functional dystrophin protein. The
gene editing therapy described here, MyoDys45-55, uses adeno-associated virus (AAV) delivery of
CRISPR/Cas9 to delete exons 45-55 in the DMD gene, correcting the reading frame for 50% of
all Duchenne patients. The restored dystrophin is three times larger than the mini/micro-
dystrophins introduced by gene replacement and is associated with a very mild or asymptomatic
form of Becker muscular dystrophy. As MyoDys45-55 progresses towards clinical trials, preclinical
data are critically needed to characterize the relationship between the amount of restored
dystrophin and improvements in function. Here, pups from a humanized mouse model of
Duchenne will be administered a range of AAV9-MyoDys45-55 doses and non-invasive functional
testing, physiology, and quantification of molecular outcomes will be conducted. Analysis will be
performed to assess how restoration of the gene edited dystrophin protein correlates to functional
benefit. These data will be used to inform trial design (including dose selection) and to support
the use of the exon 45-55 deleted dystrophin as a clinical biomarker and potential surrogate
endpoint for accelerated approval. Importantly, there is clear regulatory precedent for this pathway
since five other Duchenne drugs have received accelerated approval based on expression of
different internally-deleted dystrophins. But FDA has also stressed the need for program-specific
preclinical and clinical evidence. Here we will perform these preclinical studies to support clinical
trials that we will initiate in the near future. This work is critical to advance MyoDys45-55 to patients
as an innovative solution for a large proportion of the Duchenne population.

Public health relevance
Project Narrative Duchenne muscular dystrophy is a rare muscle wasting disease leading to premature death with no cure. To prepare for clinical trials of a gene editing therapy for 50% of Duchenne patients, assessment of the restored protein and how it correlates to improved function in preclinical models is needed. The work performed here will gather data for the use of a gene edited dystrophin protein as a biomarker and potential surrogate endpoint which will influence the design of future clinical trials in this devastating disease.